Temple Strategies to Innovate EmeRgENcy Care Clinical Trials Network (Temple-SIREN)

The Temple-led Emergency care research network (Temple-SIREN) is comprised of multiple community and academic medical centers and EMS providers throughout Philadelphia, New Jersey, Delaware, and Maryland to execute SIREN emergency care trials. To meet the needs for specific study enrollment, Temple-SIREN engaged the highest volume emergency and trauma centers and the busiest EMS systems in the region. Temple-SIREN Hub and spoke leaders are committed to emergency care research and are active in trials of acute cardiopulmonary and neurological illness and traumatic brain injury trials. Through collaboration and hub oversight, the Temple-SIREN group expects to significantly contribute SIREN studies' enrollment. In addition, we plan to stay ahead of the curve by translating preclinical work to the bedside and using our regional network for studies that address the needs of our local population. The Temple-SIREN Hub staff will work closely with participating site investigators and coordinators from multiple disciplines to efficiently execute SIREN studies. Mechanisms to enhance efficiency and quality of clinical research across sites include use of a common informatics system to identify potential study patients; frequent communication with investigators and coordinators via webinars and conference calls; diligent site management focused on good clinical research practices and compliance, and regular Hub-spoke meetings to provide additional training by study role. Temple-SIREN investigators and coordinators will participate in SIREN clinical coordinating center and data management center and ad hoc working groups to develop SIREN studies

Public health relevance
Well-conducted multi-center emergency care research can benefit patients with acute illness and injury. Temple researchers collaborate with emergency medicine, pulmonary, neurology and trauma experts to conduct trials in hospitals in Philadelphia and the surrounding region aimed at improving the treatment of acutely ill and injured patients.